Noninvasive Targeted Neuromodulation

Summary
Neurological and psychiatric disorders absorb one-third of the total health care expenditures; more than cancer, cardiovascular diseases, and diabetes combined. On average, approximately one in three patients fails to respond to medication treatments or has intolerable side eﬀects. Neuromodulation, which aims to treat brain disorders at their neural source, provides a new path to eﬀective and personalized treatments. Unfortunately, existing invasive neuromodulation approaches are currently limited to speciﬁc patients and brain targets, and noninvasive approaches do not have the necessary spatial resolution. As a consequence, a large proportion of patients do not receive adequate treatment. To address this issue, we have developed a non-invasive approach and hardware that enable noninvasive and targeted neuromodulation. The tool modulates speciﬁc brain targets on command and at high spatial and temporal resolution. The approach has the precision of implanted electrodes but is applied remotely and entirely noninvasively. To achieve this, the approach combines two forms of noninvasive energies—focused ultrasonic and magnetic ﬁelds. The product of these ﬁelds generates localized electrical stimulation (“Lstim”). The ultrasound bestows Lstim with sharp focus and targeting ﬂexibility. The stimulated regions can be as small as a grain of rice deep in the human brain. To realize the potential of the method, we have developed a programmable transducer array that can target speciﬁed brain regions rapidly on demand, enabling the stimulation of multiple brain targets in succession or concert. We have validated the neuromodulatory eﬀects of Lstim in the peripheral nervous system of 18 human subjects. We now propose to develop eﬀective and safe Lstim protocols for modulating deep circuits in the brain and thus harness the full power of the approach. We will perform the work in non-human primates to maximize clinical relevance and accelerate translation. Speciﬁcally, we will determine which Lstim parameters excite and inhibit neurons most eﬀectively (Aim 1). We will target deep brain visual regions and assess the magnitude and polarity of the neuromodulatory eﬀects using an established electrophysiological readout. We will validate the safety of Lstim using a sensitive behavioral task, contrast-enhanced MRI, and histological examination of brain slices (Aim 2). The completion of these two aims will maximize the eﬀectiveness of a new, non-invasive and targeted neuromodulation technique and validate its safety. The approach has the potential to provide treatment options for a large number of medication-resistant patients. We will disseminate the developed hardware along with the eﬀective protocols for the beneﬁt of clinicians, patients, and researchers.

Public health relevance
Narrative We will develop a noninvasive targeted neuromodulation tool. The tool will enable scientists to manipulate brain function in humans, and provide a treatment option for patients with treatment-resistant neurological and mental disorders. The development of this new technology and the intended use resonate with the mission of the NIH Brain Initiative.